SAFETY AND IMMUNOGENICITY OF VACCINIA-DERIVED HIV-1 RECOMBINANT ENV GLYCOPROTEIN

To determine the safety of vaccinia-derived HIV-1 recombinant envelope glycoprotein (RGP160) in human volunteers. To evaluate the immunogenicity of this preparation in human volunteers.